Investigating a Model for PM-Induced Exacerbation of Autoimmunity

Epidemiologic studies strongly support that exposure to airborne pollution increases the incidence and severity
autoimmunity, a diagnosis that encompasses more than 80 different disease processes and affects more than
20 million Americans. Patients typically suffer chronic symptoms that leave them ill for the rest of their lives.
Surprisingly, despite the fact that inhaled particulate matter (PM) is well accepted as a risk for autoimmunity,
the specific exposures that cause disease and the mechanisms involved are not known. This is likely because
of the complexity of pollution that is generated by numerous sources with variable chemical composition, and
the diverse genetic background of populations that are exposed. This lack of understanding has made efforts
at regulation, remediation, and avoidance unsuccessful. Veterans may be at particularly high risk, as military
personnel are exposed to high levels of PM from diesel engines and other sources. In addition, some unique
exposures that may be particularly pathologic are found at sites of deployment, including burn pit exposures.
Our group has spent the last few years examining the ability of different samples of PM to enhance an effector
response and increase immunity. We have recently found that in a mouse model of experimental autoimmune
encephalomyelitis (EAE), two Standard Reference Materials (SRMs) from diesel exhaust particles (DEP)
significantly increased severity of disease. Analysis of the organic fractions of these samples show aryl
hydrocarbon receptor (AHR)-dependent ability for enhancement of effector Th17 cell differentiation by these
samples. In addition, analysis of polycyclic aromatic hydrocarbon (PAH) mixtures from these samples suggest
this fraction may be central to the increased effector response in T cells. These findings have led us to
generate the hypothesis that exposure to military service or deployment-related PM can increase self-
reactive T-cell responses in an AHR-dependent manner, resulting in more severe autoimmune disease.
We will explore the following aims: Aim 1: Identify DEP-mediated effects on T cells that lead to an
increase in EAE clinical severity. We will test the hypothesis that DEP exposure in the B6-EAE model
enhances disease severity by increasing the pathogenic potential of anti-MOG T cells, either directly through T
cells or indirectly through DCs. This aim focuses on effects on immune cells irrespective of a role for the AHR
Aim 2: Determine the contribution of the AHR, metabolism, and the PAHs in PM-driven autoimmune
exacerbation. We will test the hypothesis that both DEPs aggravate EAE via the AHR, and will explore the
importance of metabolism and PAH content.
Aim 3: Screen source samples of military service or deployment-related PM for immune-altering
activity. We will expose mice undergoing EAE to four samples relevant to military exposures, testing the
hypothesis that aggravation of autoimmunity is source dependent.
Aim 4: Determine the capacity of dietary interventions to mitigate DEP-mediated aggravation of
disease in the B6-EAE model. We will test the hypothesis that dietary ligands can specifically reduce the
effects of inhaled pollution on autoimmunity.
We anticipate that PM will aggravate EAE through a direct effect on the AHR in T cells. We further predict that
exposures unique to the military will aggravate disease, and oral supplementation with dietary AHR ligands will
mute the aggravation of disease seen after PM exposure. This grant directly addresses the priority research
area of interest regarding military service or deployment-related occupational exposures. Results from this
grant will provide a rational for understanding which military environmental exposures are most pathogenic and
aid in remediation, avoidance, and treatment strategies.

Public health relevance
It is well accepted that exposure to inhaled pollution aggravates autoimmunity, although the mechanism and the specific exposures remain unclear. This is particularly relevant to veterans, who are exposed to higher levels of inhaled particulate matter than the general population when on active duty. In addition there are unique exposures during deployments, including burn pit smoke, which have the potential to be particularly pathogenic. In this proposal we will show that intranasal samples of diesel exhaust aggravate autoimmunity in mice. We will perform experiments to define the mechanism of disease aggravation by pollution. We will test the effects of a few specific military exposures in our model, and explore the ability of dietary supplements to prevent worsening of disease after inhalation of pollution. The findings will facilitate development of avoidance and regulatory strategies and pinpoint treatment options for our veterans at risk for autoimmune disease secondary to pollution.